Health Research Institute- Validation study of California Breast Cancer Registry Data with Synthetic Census Tracts

Health Research Institute- Validation study of California Breast Cancer Registry Data with Synthetic Census Tracts